Tracking early emergence of sound perception impairments in FXS with multimodal fNIRS/EEG

Project Summary_Abstract
The purpose of this K23 is to provide the training, mentorship, and research experiences needed for the
applicant to become a successful independent clinical scientist with a research program focused on
understanding mechanisms linking sensory anomalies, brain dysmaturation, and speech and language
impairments in neurodevelopmental disorders. The training plan focuses on developing skills required to
measure and understand the behavioral, auditory, and neurophysiological indices of early speech and hearing
development in Fragile X Syndrome (FXS), with three specific areas of emphasis: 1) statistical methods and
signal processing techniques required for cutting edge analysis of functional neurophysiology (fNIRS/EEG), 2)
development of the auditory system and speech/hearing in infancy and 3) research methods and ethics for
studying infants and very young children with FXS. Dr. Craig Erickson along with co-mentors Dr. John
Sweeney and Dr. Lisa Hunter will provide the mentorship, training, and resources necessary to achieve the
training objectives. This research program is relevant to several objectives listed in the NIH Research Plan on
FXS and Associated Disorders, including but not limited to objectives 3.1 (Develop a standard battery of
functional, objective measures to better characterize the emergence of the FXS phenotype across the life span
and provide precise indicators of treatment effectiveness) and 3.4 (Conduct longitudinal studies of both
humans and animal models to characterize the dynamic nature of the FXS phenotype across the life span and
to identify moderators and mediators of the phenotype).
FXS can be diagnosed in the infant and toddler years given its genetic/heritable etiology. However,
current understanding of atypical maturation of brain function in FXS and its clinical manifestations is entirely
based on studies of older children (5+), adolescents, and adults, at which point impairments associated with
the disorder, including delays in speech and language, have been present for several years. Thus,
understanding of neural mechanisms and timing of the early brain dysmaturation that lead to early delays in
FXS remains limited, which in turn limits development of interventions. The proposed career development plan
provides the PI with the skills to address this gap in brain-based markers of impairment in early FXS. The
research plan uses EEG/fNIRS, auditory evaluations, and speech and language assessment to investigate
auditory hypersensitivity and its relation to emergence of speech and language delays in FXS. This study
occurs in two phases, with the first focusing on preschoolers (2-4 years) and the second, longitudinal phase
focused on the infant years (0-2 years).Thus, the aim of this early career development program is to prepare
the investigator to establish an independent research program focused on determining the timing and nature of
brain dysmaturation that leads to early speech and communication impairment in FXS.

Public health relevance
Auditory sensory anomalies and speech and language impairments are common and impairing in individuals with Fragile X Syndrome (FXS), but the biological basis of these impairments and their developmental trajectory in the infant and toddler years has not been systematically investigated. This limits mechanistic understanding of these features and development of brain- based biomarkers for treatment development in early life when interventions may be most effective. This project combines multimodal neural measures (EEG/fNIRS), speech and language assessment, and audiological measures to address this gap by: 1) characterizing auditory hypersensitivity at the neural level and its relation to speech and language functioning in preschoolers with FXS, and 2) tracking the emergence and developmental progression of neural substrates of auditory, speech and language difficulties in the infant years, with the longer term goal of informing and improving early interventions.